A network for diverse cohort selection, precision tissue preparation and quantitative neuropathological characterization of Alzheimer's Disease and comorbid dementias.

ABSTRACT (PROJECT 1)
The overarching goal of Project 1 is to facilitate development of a diverse cohort of brain donors across the spectrum of
Alzheimer’s disease (AD) and AD-related comorbid dementias (ADRD) with optimally preserved and characterized brain
tissues for multimodal analysis including integrated diagnostic and quantitative neuropathology (Project 1), next
generation single nucleus Multiome (Project 2), and spatial transcriptomics and proteomics (Project 3). To accomplish this, we propose to create a multisite Neuropathology Core Network (NCN) where we apply state-of-the-art methods to build a diverse pool of brain donor candidates for SEA-AD2.0 with optimally preserved and characterized tissues spanning AD and AD/ADRD (Aim 1). We propose a national network of ADRC neuropathology cores and community-based studies that have or will adopt modern tissue collection and characterization methods that will then be applied to all prospective
donors. Donor brains from the NCN will undergo thorough neuropathological examination with oversight of a
Neuropathology Consensus Panel (NCP) to promote consistent application of standard criteria and to develop and test
novel diagnostic criteria that may benefit the broader neuropathology community. From the NCN donors, we will
assemble a SEA-AD2.0 donor cohort with guidance from a Diversity and Donor Selection Committee whose members
include experts in neuroethics, neurodiagnostics, and clinical and basic neuroscience (Aim 2). Our goal is to build a diverse
and deeply phenotyped SEA-AD 2.0 cohort including donors from underrepresented racial and ethnic backgrounds and/or
with early AD neuropathology or AD plus AD-related comorbid dementias/pathologies, cognitively normal aged donors
without AD pathology (resistance) or those with high levels of AD pathology (resilience). We will prioritize donors with
rich longitudinal clinical and biomarker characterization for inclusion in the SEA-AD2.0 cohort. Once selected, 3D brain
surface scanning and high-resolution photographic data from each site will be used for volumetric reconstruction of each
brain, registration with a common coordinate framework, and parcellation of brain slice images to maximize anatomical
precision for sampling and downstream analyses. In Aim 3, we apply advanced quantitative neuropathological methods
to precisely map neurodegeneration across the brain to inform single nucleus (Project 2) and spatial (Project 3) -omics
studies. Fixed tissues from multiple brain regions will be sent to UW from each NCN site to be stained, scanned, and
annotated for multifactorial quantitative neuropathological analysis focused on pathologic peptide burden, neuronal and
glial populations and morphologies, and neuroinflammation. We have selected five core brain regions that capture the
broad range of AD and AD/ADRD pathological progression, and up to 20 additional regions to enhance coverage of early
pathology, of functionally relevant areas within connectivity networks, and areas that subserve specific cognitive domains
in AD. When completed, Project 1 will have created a diverse cohort with optimally preserved and characterized tissues
for multimodal neuropathological and molecular analyses designed to identify early vulnerable cells and mechanistic
pathways in AD and AD/ADRD.

Public health relevance
PROJECT NARRATIVE (PROJECT 1) The first phase of SEA-AD developed state-of-the-art neuropathology and neuroscience protocols for tissue collection, preservation, and characterization that enable deep quantitative molecular and cellular characterization of Alzheimer’s disease (AD) to identify early vulnerable cell types and disease mechanisms. In SEA-AD2.0, we extend these advancements across an exceptionally diverse and balanced cohort composed of donors selected from a Neuropathology Core Network through a process informed by neuroethics, neuropathology, and clinical and basic neuroscience. Project 1 will produce a unique cohort of brain donors enriched for diversity of age, sex, race, ethnicity, AD-related comorbid pathologies, and AD resistance and resilience mechanisms with optimally preserved tissues that are characterized by highly quantitative, multiregional, and multimodal neuropathology to inform downstream genomics applications, and ultimately enable creation of a rich AD community data resource.